TRIAL OF TESTOSTERONE REPLACEMENT THERAPY IN HIV INFECTED HYPOGONADAL MEN

To determine if giving the male hormone, testosterone can increase lean muscle mass in men infected with HIV virus who have low blood levels of testosterone.